Animal Husbandry Core

Abstract – Core A: Husbandry and Management Core
Indian-origin rhesus macaques are a premier model for AIDS research, but current research demand far exceeds
supply. This has been exasperated by the COVID-19 pandemic, where rhesus have proved again to be a vital
model for the development of vaccines and therapeutics. This project will help alleviate this shortage by the
production of Indian-origin, specific pathogen free (SPF) rhesus macaques prioritized for AIDS-related research
that are well characterized by genotype and phenotype. Using established methods, we will utilize genomic,
behavioral, and demographic data to optimally compose and monitor rhesus breeding groups. We will also
increase the size of our rhesus colony via an increase in the number of female breeders, institutionally supported
acquisition of additional macaques for breeding and/or research purposes, and occupation of newly renovated
areas for rhesus production. We will continue to provide rhesus for AIDS-related and other approved NIH
research. Towards this end, we will focus on Specific Aim 1: maximize the genetic diversity and production
efficiency of the SNPRC SPF breeding colony by genetically and reproductively managing it in concert with the
MHC Genetic Typing Core and Specific Aim 2: grow the U42 Colony towards an approximate steady state of
1000 animals, at which time approximately 150 rhesus macaques will be made available for AIDS research
annually. The rhesus macaque colony supported by this U42 will continue to serve as a critical national resource
for AIDS investigators.

Public health relevance
Narrative – Core A: Husbandry and Management Core This project will manage a U42-supported production colony of SPF Indian-origin rhesus macaques prioritized for AIDS-related research. Goals include a planned increase in colony size, and ultimately an increased number of rhesus available for approved research projects, in response to unprecedented national demand. A coordinated team of managers, veterinarians, behaviorists, geneticists, virologists, and resource scientists will oversee this critical national resource.